Personalized Cystic Fibrosis Therapy and Research Center

PROJECT SUMMARY:
A foundational component of this P30 application is the Personalized Clinical Core, which will be the
primary source of human cells, tissues, biofluids [e.g.: sweat, serum, sputum, bronchoalveolar lavage fluid
(BALF),] and translational research expertise. The Personalized Clinical Core builds directly on current clinical
research strengths and infrastructure at CCHMC, CSMC and UCCOM including the CFF-TDN program, the
CF-RDP program, investigator-initiated research, and institutional commitments to CF translational research.
The Personalized Clinical Core will expand these capabilities in critical ways, operationalizing novel
translational research projects and providing direct patient relevance to cutting-edge basic science. The long-
term goal of this core is to support basic science CF research with patient-derived samples from the clinic into
the laboratory, and high-quality translational research moving laboratory findings into the clinic. This will be
achieved through three specific aims. Specific Aims 1 and 2 will capitalize on existing partnerships and
infrastructure to obtain, bank, and distribute high-quality gastrointestinal and respiratory samples, respectively,
from CF and non-CF controls, paired with relevant patient data. Specific Aim 3 will provide the tools
necessary to execute cutting-edge translational studies in CF, including expertise and support in novel disease
markers and endpoints.
Centralizing these capabilities through the Personalized Clinical Core structure will help to drive
research efficiencies and standardization. In addition, the samples obtained and processed through the
Personalized Clinical Core will be available for direct use by CF researchers, and for projects utilizing the
Personalized Model System Core and the CF-Organ-On-a-Chip Core.